Toward translation of flexSTIM: a biomimetic implanted pattern generator for effective long-term pressure injury prevention through automatedweight shifting and enhanced tissue health.

Pressure injury (PrI) prevention remains a major challenge over the long term for Veterans with impaired
mobility, in particular those with spinal cord injury (SCI). PrI limit activities of daily living, often leading to
prolonged bedrest, hospitalization and even death. Clinical practice guidelines recommend weight-shifting
every 20 minutes for persons with SCI, which is impractical when busy with activities of daily living. We have
previously shown that long term use of dynamic gluteal intermittent stimulation (iGSTIM) using percutaneous
electrodes and an external stimulator effectively provides an extra means of weight shifting, improves local
blood flow, increases muscle size and reduces the incidence of tissue breakdown, specifically pressure
injuries. User feedback was that long-term use of iGSTIM meant they no longer worried about recurrent skin
problems requiring significant periods of bedrest. Furthermore, daily use of the system was easy and fit well in
to their activities of daily living. However, continued usage is necessary to sustain improvements in tissue
health and the need to keep percutaneous lead exit sites covered and regularly cleaned became arduous over
time. Users requested a fully implanted iGSTIM for regular weight shifting and PrI prevention.
Our team has been contacted many times over the years by individuals asking for a system that could be
entirely implanted. Other prevention methods these individuals tried have failed and they are desperate for a
new alternative. We have therefore developed the flexSTIM biomimetic implantable pulse generator (IPG).
Prior funding synergized recent advances in flexible hybrid electronics, additive manufacturing and packaging
with our prior clinical findings to provide initial development and testing of the flexSTIM IPG laying the
foundation for translation and clinical implementation in persons with SCI. Combined with industry-standard
intramuscular electrodes, the VA-patented flexSTIM IPG is a novel technology that proactively addresses the
issues of decreased muscle quality and the long-term need for regular weight-shifting for persons with limited
mobility, in particular Veterans with SCI. This small flexible 2-4 channel system meets the end user need for
straightforward automated weight-shifting and can be initiated daily at the touch of a button. flexSTIM is
designed to be inserted into a subcutaneous pocket through a 1” incision, with the whole iGSTIM system
implemented as an outpatient procedure.
The overall goal of this TRRA-1 planning grant is to complete review of technical merit of the research
completed to date together with evaluating the further testing proposed, in order to assemble the detailed
documentation necessary for a pre-IDE (Q-Sub) meeting with the FDA on the iGSTIM system including
implanted flexSTIM Class III IPG and intramuscular electrodes with an external (primary) coil. Specific activities
will include: Management of regulatory tasks including regulatory file maintenance and Master file ratification
together with review of further in-vivo testing so that the FDA can provide clear guidance on the preclinical
testing needed for the IDE submission. The conditionally approved IRB protocol proposed under the requested
IDE will also be reviewed. The current study design would evaluate whether use of the fully implanted iGSTIM
system using the flexSTIM IPG to deliver neuromuscular electrical stimulation to the buttocks provides reliable
regular weight shifting and improves the health of the muscles over time in 10 Veterans with SCI. The initial
pre-IDE meeting will be scheduled during the third quarter of the planning grant. The fully implanted iGSTIM
system has enormous potential to enhance health and quality of life for Veterans with SCI.

Public health relevance
Pressure injury (PrI) prevention is a major challenge for many Veterans with spinal cord injury (SCI), often leading to prolonged bedrest, hospitalization and even death. We have shown that sustained use of gluteal intermittent stimulation (iGSTIM) provides effective automated weight shifting and reduces PrI. Users said that long-term iGSTIM usage meant they no longer worried about recurrent skin problems, with daily use fitting easily into their lives. However, a fully implanted iGSTIM system was requested. We have also been contacted by many people desperate for a new alternative to PrI prevention and asking for a simple fully implanted system. We therefore developed the innovative VA-patented flexSTIM biomimetic implantable pulse generator that in combination with industry-standard intramuscular electrodes, provides a fully implanted iGSTIM system for regular automated weight-shifting at the touch of a button. This planning grant will support preparation for a pre-IDE meeting with the FDA to establish clear preclinical testing criteria for first-in-human testing.